Epigenetic control of smooth muscle cell phenotype during microvascular remodeling

PROJECT SUMMARY
Peripheral Artery Disease (PAD) is an occlusive disease of the lower extremity arteries leading to debilitating
complications (e.g., claudication, amputation) due to defects in proper vascularization and efficient vascular
remodeling. Recent attempts to promote therapeutic angiogenesis by VEGF therapies in patients with PAD have
failed, perhaps because these strategies have only not targeted smooth muscle cells (SMC). These cells are
essential for remodeling capillaries and terminal arterioles (i.e., arteriogenesis). Arteriogenesis relies on the
ability of SMC to be plastic and undergo a reversible phenotypic switching where they transiently downregulate
their contractile apparatus, participate in micro-vessel investment, and then re-differentiate back to the contractile
state. However, the understanding of the mechanisms controlling SMC ability to re-differentiate and the retention
of their lineage memory in vivo is limited. During the original funding cycle of this project, we demonstrated that
the histone post-translational modification H3K4 di-methylation (H3K4me2) governs SMC lineage identity and
transcriptional memory on the SMC gene repertoire. Mechanistically, H3K4me2 is essential for recruiting the
methylcytosine dioxygenase and SMC master regulator, TET2, on the SMC genes. Our preliminary data suggest
that loss of TET2 expression is associated with defective migration in SMC and lack of participation in
microvascular remodeling during hindlimb ischemia. We found that hypoxia caused a concomitant increase in
TET2 expression and a reduction in TET2 dioxygenase activity. These data support a major shift in the current
paradigm in that TET2 might display functions beyond the pro-contractility role previously reported but may be
involved in both contractility and migration in a context-dependent and dioxygenase-dependent manner. Studies
in this proposal will test the central hypothesis that TET2 mediates hypoxia-induced SMC migration and adaptive
vascular remodeling through non-canonical non-dioxygenase function. Aim 1 will determine whether TET2
controls SMC migration through dioxygenase-independent function in hypoxia-mediated angiogenesis and
arteriogenesis in a series of in vitro and in vivo studies. Aim 2 will delineate the epigenetic mechanisms by which
TET2 regulates SMC gene expression in hypoxia. Finally, Aim 3 will determine whether TET2 deficiency in SMC
leads to defective adaptive vascular remodeling, decreased tissue perfusion, and SMC dysfunction in hindlimb
ischemia (HLI). We expect the completion of these studies will lead to the identification of novel mechanisms
controlling smooth muscle cell plasticity, migration, and participation in beneficial microvascular arterialization
and maturation. These results could serve to develop new strategies for enhancing therapeutic vascularization
in patients with PAD.

Public health relevance
NARRATIVE Peripheral Artery Disease is an occlusive disease of non-cardiac and non-intracranial arteries affecting over 8.5 million patients in the US and leads to morbid and debilitating complications including lower extremity ischemic ulceration, gangrene, and eventually amputation due to a defect in tissue vascularization. Since recent attempts to promote vascularization by therapeutic endothelial cell-mediated angiogenesis have failed, there is a need to define mechanisms controlling and promoting the participation of smooth muscle cell in microvascular remodeling. The studies of this proposal will identify the functional role of epigenetic programming, major regulatory process of cell gene expression, in controlling smooth muscle cell migration and participation in microvascular remodeling and may lead to novel therapeutic approaches to improve lower extremity vascularization in patients with Periphery Artery Disease.